Glycopeptide vancomycin reshapes gut microbiota to mediate cardioprotective effects via microRNA-204

SUMMARY
Left ventricular (LV) pressure overload caused by conditions such as chronic hypertension or aortic stenosis is
a significant risk factor for the development of heart failure. A decline in microbial diversity caused by certain
antibiotics also increases the risk of heart failure, suggesting that the gut harbors cardioprotective microbes.
However, our current knowledge of which microbes are cardioprotective and which have deleterious cardiac
effects is inadequate, not allowing us to leverage gut microbial manipulation with antibiotics to treat or mitigate
heart failure. microRNA-204-5p (miR-204) is a noncoding RNA well-expressed in mouse and human hearts.
We recently reported that the miR-204 inhibits mouse myocardial hypertrophy induced by experimental
pressure overload, and its expression in many tissues, including the heart, is sensitive to changes in the gut
microbiome.
Our preliminary data show that glycopeptide antibiotic vancomycin alters the mouse gut microbial landscape,
leading to the enrichment of Lactobacillus sp that confers protection from pressure overload-induced
myocardial hypertrophy and LV dysfunction. Moreover, vancomycin increases the abundance of the bacterial
metabolite tryptamine in the feces and serum, which inhibits myocardial hypertrophy and LV dysfunction. Both,
vancomycin and tryptamine stimulate cardiac miR-204 expression, which is essential for their cardioprotective
effects. Based on these data, we hypothesize that vancomycin-induced reshaping of the gut microbiome
enriches Lactobacillus sp. that promotes tryptophan's metabolism to tryptamine, leading to upregulation of
cardiac miR-204 that inhibits pressure overload-induced myocardial dysfunction.
This application will leverage unique reagents and tools to connect vancomycin-induced reshaping of the gut
microbiome to cardiac miR-204-regulated cardioprotection. The application will determine whether
vancomycin-induced enrichment of Lactobacillus sp. in the gut stimulates bacterial tryptophan metabolism to
confer protection from myocardial hypertrophy and LV dysfunction. Next, we will explore the role of cardiac
miR-204 in mediating the cardioprotective effect of vancomycin on pressure overload-induced myocardial
hypertrophy and LV dysfunction. We expect our study to identify specific microbes (e.g., Lactobacillus
murinus), metabolites (e.g., tryptamine), and signaling intermediaries (e.g., miR-204) that mediate the
cardioprotective effects of vancomycin.
There is a crucial knowledge gap in our understanding of how the gut microbiome modulates cardiac
contractile function. This gap is a hurdle to using gut microbiome manipulation as a therapeutic strategy for
heart failure. This application will narrow this gap by exploring a novel nexus between gut bacteria, bacterial
metabolites, and cardiac miR-204.

Public health relevance
PROJECT NARRATIVE A decline in microbial diversity caused by certain antibiotics increases the risk of heart failure, suggesting that the gut harbors cardioprotective microbes, but microbial reshaping that improves cardiac resistance to hypertrophic stress is unknown. This proposal will test the hypothesis that vancomycin-induced reshaping of the gut microbiome enriches Lactobacillus sp. that promotes tryptophan's metabolism to tryptamine, leading to upregulation of cardiac microRNA-204-5p that inhibits myocardial hypertrophy and dysfunction. The completion of this project is expected to identify specific microbes (e.g., Lactobacillus murinus), metabolites (e.g., tryptamine), and signaling intermediaries (e.g., miR-204) that mediate the cardioprotective effects of vancomycin, and these findings will be relevant for mitigating heart failure.